IGNITE KUH Administrative Core

ADMINISTRATIVE CORE ABSTRACT
The Integrated Virginia Research Training Centers in Kidney, Urology and Hematology (IGNITE KUH) is based
on a collaborative partnership involving three main research training centers in the Commonwealth of Virginia -
University of Virginia, Virginia Commonwealth University, and Virginia Polytechnic Institute and State University
- and is committed to developing the next generation of KUH researchers. The IGNITE KUH administrative core
will provide a unified, integrated structure for the program and will provide oversight and governance. The
Administrative Core provides the resource provisioning, scheduling, governing, and reporting functions. The
importance of diversity, equity and inclusion is supported within our own leadership group, including program
directors (PD) and Internal Advisory Committee (IAC) members and will continue with selection of future External
Evaluation Board (EEB) members. Our governance structure, composed of PD from the 3 core institutions, is
based on a transparent process of decision-making and conflict resolution across the administrative leaders.
This approach allows for discussion and thoughtful consideration of options and impacts. Outcomes and
progress will be measured by grants, publications, trainee career advancement, recruitment, diversity, equity
and inclusion, and lastly awards (including patents, patent applications, research outcomes, new collaborations
and the development of new innovative programs). We propose the following specific aims: 1) To integrate and
facilitate the development of a unified research community among the core institutions to produce a fertile and
expansive training environment for pre- and postdoctoral trainees. 2) To channel and manage input through
coordinated communication. 3) To facilitate and rigorously evaluate the outcomes of the integrated collaborative
structure facilitated by IGNITE KUH. The complexity of the program requires professional expertise in an
unbiased, independent review, which will be performed through assistance from UVA’s Center for Survey
Research, to assure success of the program. The ultimate long-term goal is to fuel a diverse workforce of highly
skilled researchers to advance therapies and impact the care of patients that suffer from KUH-related diseases.